Biologic and Functional Characterization of In Vivo CAR-T cells

Project Summary
Chimeric Antigen Receptor (CAR) T cell therapy has revolutionized treatment for B cell malignancies by
targeting T cytotoxicity to the site of the tumor. Despite the success of CAR-T cells in B cell malignancies, more
than half of patients receiving CAR-T cell treatment fail to achieve long term disease control. Therapeutic
failure can be attributed to many causes including the inverse relationship between CAR-T cell manufacturing
duration and the resulting anti-tumor potency. Additionally, CAR-T cell manufacturing poses barriers to access
such as cost and difficulty meeting supply demand equilibrium. To engineer the next generation of CAR-T cells
with enhanced anti-tumor efficacy and greater patient access, I will generate CD19.28z CAR-T cells in vivo
using modified lentiviral particles engineered to express a T cell targeting antibody fragment, referred to in this
proposal as the Programmable Antibody-mediated Cellular Knock-In of T cells (PACK-IT) system. The PACK-IT
system will be used to explore my central hypothesis: engineering T cells in vivo is feasible and will deliver a
more efficacious CAR-T cells (PACK-IT CAR-T cells) with distinct biologic features, reducing cost and
increasing access. I have demonstrated feasibility of the PACK-IT system to generate functional CD19.28z
CAR T cells in vitro and extended the use of the PACK-IT system to successfully transduce T cells in tumor
bearing mice. Based on the proof-of-concept experiments, I propose to (i) optimize the PACK-IT system in
terms of transduction efficiency, phenotype, and anti-tumor potency of resulting CAR-T cells, (ii) in vivo
comparison of PACK-IT CAR-T cells and those made via conventional manufacturing, and (iii) assess the
impact of armoring PACK-IT CAR-T cells with drug regulatable cytokine receptors on anti-tumor potency in
immunocompetent hosts. Collectively, the proposed work will result in a method to produce CAR-T cells in
vivo, allow rigorous characterization of the impact of eliminating the ex vivo manufacturing process, and
develop PACK-IT CAR-T cells armed with regulatable cytokine receptors to boost T cell function in vivo. The
proposed work will take place at Stanford University School of Medicine, a leading institution in immunology
and immunotherapy and a setting that emphasizes innovation. Dr. Crystal Mackall is the ideal sponsor for this
project due to her extensive track record of mentoring successful physician scientists and her expertise in T
cell biology and translational therapeutics. In addition, I will be supported by a multidisciplinary team including
mentorship from Drs. Howard Chang (genome wide sequencing, engineered lentiviral vectors), Christopher
Barnes (structural virology), and Anusha Kalbasi (engineered cytokine receptors).

Public health relevance
Project Narrative Chimeric Antigen Receptor (CAR)-T cell immunotherapy has shown impressive response rates in B cell malignancies; however, limitations to access and failure of many patients to reach complete response call for therapeutic enhancement. Although the causes for CAR-T cell failure are multiple and still emerging, the time necessary to manufacture CAR-T cells seems to directly correlate with quality: the longer the manufacturing time, the worse performance of CAR-T cells once infused into the patient. We hypothesize that platforms enabling in vivo engineering of CAR-T cells will enhance CAR-T cell quality and efficacy with less expense and greater patient access.